To Elucidate the Biological Function and Translational Potential of NLRP3 in Immunotherapy-resistant Melanoma

)', ! ,!#/ '0 1&# +-01 !-++-, $-/+ -$ ! ,!#/ ', 1&# ,'1#" 1 1#0 ," +#* ,-+ !!-2,10 $-/
1&# 3 01 + (-/'16 -$ 0)', ! ,!#/ "# 1&0 -1 *6 #1#/ ,0 & 3# , ',!/# 0#" /'0) -$ "#3#*-.',%
," "6',% -$ +#* ,-+ !-+. /#" 1- 1&# %#,#/ * .-.2* 1'-, * #'1 '++2,-1&#/ .6 4'1& '++2,#
!&#!).-',1 ',&' '1-/0 & 0 /#3-*21'-,'7#" 1&# 1/# 1+#,1 -$ +#* ,-+ 0'%,'$'! ,1*6 '+./-3',%
1&# -21!-+# -$ . 1'#,10 4'1& 1&'0 "'0# 0# 1&# -21!-+#0 /#+ ', .--/ $-/ #1#/ ,0 4'1& "3 ,!#"
+#* ,-+ 2/1&#/+-/# -,*6 -$ . 1'#,10 #5.#/'#,!# * 01',% +#"'! * #,#$'10 $/-+
&# ! ,"'" 1#80 *-,% 1#/+ %- * '0 1- "#3#*-. ,#4 1&#/ .#21'! 01/ 1#%'#0 '+#" 1 1 /%#1',% 1&'0
02 .-.2* 1'-, &# 0'%,'$'! ,1 ,2+ #/ -$ /#$/ !1-/6 ," /#* .0# ! 0#0 /#./#0#,10 , '+.-/1 ,1
2,+#1 !*','! * ,##" $-/ 1&# 1/# 1+#,1 -$ +#* ,-+ ," ./-3#0 1& 1 '++2,# /#%2* 1-/0 02!& 0
," /# ,-1 1&# -,*6 "#1#/+', ,10 -$ +#* ,-+ ./-%/#00'-, ," '++2,#
#3 0'-, -1 *6 4&'*# ',$* ++ 1'-, & 0 ##, "#+-,01/ 1#" 1- ',$*2#,!# +#* ,-+ %/-41& ,"
/#0.-,0# 1- !&#!).-',10 ',&' '1-/0 ,- 1&#/ .6 "#3#*-.#" 1- " 1# '0 "#0'%,#" 1- 1 /%#1 '1 &'0 '0
#! 20# 1&# 12+-/ ',$* ++ 1-/6 . 1&4 6 0 1& 1 $ !'*'1 1#0 +#* ,-+ ./-%/#00'-, ," /#"2!#0
1&# /#0.-,0# 1- '++2,-1&#/ .6 /# 01'** .--/*6 !& / !1#/'7#" -/ 1&'0 /# 0-, 1&# ! ,"'" 1#80
/#0# /!& & 0 $-!20#" -, +#* ,-+ ',"2!#" ',$* ++ 1'-, 4'1& 1&# %- * -$ '"#,1'$6',%
-..-/12,'1'#0 $-/ 1&#/ .#21'! ',1#/3#,1'-, &# &6.-1�'0 -$ 1&'0 012"6 '0 1& 1 ,"
.6/', "-+ ', !-,1 ',',% !1'3 1'-, /#"2!#0 1&# #$$'! !6 -$ '++2,-1&#/ .6 4'1&
!&#!).-',1 ',&' '1-/ 6 ',"2!',% +6#*-'" "#/'3#" 02../#00-/ !#**0 0 #5. ,0'-, 2*1'+ 1#*6
02../#00',% 1&# ," !#**0 !1'3'16 &# ! ,"'" 1# $2/1&#/ &6.-1�'7#0 1& 1
',&' '1'-, ! , /#3#/0# 1&# '++2,-02../#00'3# 12+-/ +'!/-#,3'/-,+#,1 1&#/# 6 /#0#,0'1'7',%
'++2,-1&#/ .6 /#0'01 ,1 +#* ,-+ 0 1- 1&#/ .6 '+ 4'** #*2!'" 1# 4&#/
/#%2* 1#0 '++2,-02../#00'3# +#!& ,'0+ 0 ',!*2"',% #5./#00'-, ', +#* ,-+ !#**0
/#"2!',% 1&# /#0.-,0# 1- '+ 4'** "#1#/+',# 4&#/ !1'3 1'-, '0 #+.*-6#" 6
+#* ,-+ !#**0 1- 02../#00 1&# &-01 '++2,# 0601#+ &# ! ,"'" 1# 4'** 012"6 1&'0 6
',3#01'% 1',% 1&# '+.-/1 ,!# -$ !1'3 1'-, -, 1&# . / !/',# !1'3'16 -$ +#* ,-+ !#**0 -,
'++2,# /#%2* 1-/6 !#**0 *')# 0 '+ 4'** ',3#01'% 1# 4&#/ ',&' '1'-, -$ ',
!-+ ', 1'-, 4'1& ,1' ',!/# 0#0 1&# /#0.-,0# ," "2/ '*'16 -$ '++2,-1&#/ .6 20',%
1/ ,0* 1'-, **6 /#*#3 ,1 +-"#* , !-,!*20'-, 1�# 012"'#0 4'** #01 *'0& 4&#/ "/'3#0
/#0'01 ,!# 1- ', +#* ,-+ ./-3'"',% ,#4 ',0'%&10 ',1- 12+-/ '-*-%6 12+-/ '++2,-*-%6 ,"
! ,!#/ 1&#/ .#21'!0

Public health relevance
The goal of this proposal is to develop an improved therapeutic strategy for immune checkpoint inhibitor-resistant melanoma. Although immunotherapy with checkpoint inhibitors has revolutionized treatment for advanced melanoma, only 40-60% of patients experience lasting medical benefits from this therapy. Notably, Veterans have an increased risk of developing and dying of melanoma compared to the general population. Thus, identifying new mechanisms to target melanoma is critical to improve survival in Veterans with this disease. Inflammation has been demonstrated to influence melanoma growth and response to checkpoint inhibitors. However, no therapy developed to date is designed to target it. NLRP3 is a central driver of melanoma autoinflammation, making it an attractive target candidate. This project will evaluate how NLRP3 regulates melanoma response to checkpoint inhibitors and will explore its potential as therapeutical target.